iCorp program for NIGMS project: Interactive Fiction story to teach college readiness executive functioning skills to college-bound students with ASD and ADHD

Summary: Our Phase I prototype, College Readiness Stories (CRS) will be based on our innovative
process that captures the knowledge and best practices from research scientists, practicing counselors,
and successful adults with the disability and encodes their experience into a human-computer interaction,
known as an Accessible Interactive Fiction (AIF) story.
We developed this process as part of two NIDILRR SBIR projects; one that enables teens with Autism
Spectrum Disorder (ASD) to build workplace readiness skills, and one that enables teens with vision
impairments (VI) to build skills for the transition to independent adult living.
Our Phase I project will answer two Specific Question:
§ To what extent do college bound students with ADHD or ASD students find an AIF story
game to be a usable and engaging system to practice College Readiness executive
functioning skills?
§ To what extent do non-experts find the Training Guide and Skill Charts useful for helping
college bound students with these disabilities improve these skills?
These questions will be answered through four Specific Aims (SA). In SA-1, we define the
specifications for the prototype AIF story game. In SA-2, create the prototype AIF story game.
In SA-3, create the Training Guide and Skill Charts. In SA-4, we assess the prototype’s usability
and engagement by recruiting CBASD students and their parents to use the AIF story game and
then measure the student’s rating of the story’s usability and engagement, and their parents rating
of the usefulness of the Training Guide and Skill Charts.
Progress: We have had numerous meetings between our development staff and the Expert team
(research scientists and teachers) to identify the specific executive functioning skills that will be
practiced in the AIF story, and to create the outline of the story and of each chapter in the story.
We have not encountered any administrative or technical challenges yet; our primary concern is
the commercial challenges that lay ahead. There are many several go-to-market alternatives; we
need to determine which is the most appropriate.
Team:
Luke Voelk, Chief Technical Officer, is a cofounder of our company, and was entrepreneur lead
in an NSF iCorp program for our other product, BuddyBooks. Luke will be the iCorp C-level
Corporate Officer, as he has a strong background in customer discovery and product
development.
August Voelk, Product Manager, will be our Technical Lead. August has managed five AIF
projects for students with disabilities, including the two mentioned above, from product
definition to customer pilots.
Our Industry Expert will be Mark Ventre, one of the investors in our company, and the former
COO of a Special Education company that was strategically acquired.
The three team members have confirmed that they are committed to the time requirements of the
program.

Public health relevance
1 EXECUTIVE SUMMARY (1 page) Summary: Our Phase I prototype, College Readiness Stories (CRS) will be based on our innovative process that captures the knowledge and best practices from research scientists, practicing counselors, and successful adults with the disability and encodes their experience into a human-computer interaction, known as an Accessible Interactive Fiction (AIF) story. We developed this process as part of two NIDILRR SBIR projects; one that enables teens with Autism Spectrum Disorder (ASD) to build workplace readiness skills, and one that enables teens with vision impairments (VI) to build skills for the transition to independent adult living. Our Phase I project will answer two Specific Question: § To what extent do college bound students with ADHD or ASD students find an AIF story game to be a usable and engaging system to practice College Readiness executive functioning skills? § To what extent do non-experts find the Training Guide and Skill Charts useful for helping college bound students with these disabilities improve these skills? These questions will be answered through four Specific Aims (SA). In SA-1, we define the specifications for the prototype AIF story game. In SA-2, create the prototype AIF story game. In SA- 3, create the Training Guide and Skill Charts. In SA-4, we assess the prototype’s usability and engagement by recruiting CBASD students and their parents to use the AIF story game and then measure the student’s rating of the story’s usability and engagement, and their parents rating of the usefulness of the Training Guide and Skill Charts. Progress: We have had numerous meetings between our development staff and the Expert team (research scientists and teachers) to identify the specific executive functioning skills that will be practiced in the AIF story, and to create the outline of the story and of each chapter in the story. We have not encountered any administrative or technical challenges yet; our primary concern is the commercial challenges that lay ahead. There are many several go-to-market alternatives; we need to determine which is the most appropriate. Team: Luke Voelk, Chief Technical Officer, is a cofounder of our company, and was entrepreneur lead in an NSF iCorp program for our other product, BuddyBooks. Luke will be the iCorp C-level Corporate Officer, as he has a strong background in customer discovery and product development. August Voelk, Product Manager, will be our Technical Lead. August has managed five AIF projects for students with disabilities, including the two mentioned above, from product definition to customer pilots. Our Industry Expert will be Mark Ventre, one of the investors in our company, and the former COO of a Special Education company that was strategically acquired. The three team members have confirmed that they are committed to the time requirements of the program. 2 I-Corps Team and Project Plan (5 pages) 1. I-Corps Team Appropriate Team Members & Appropriate Background Our iCorps Team combines the expertise of one of our three founders (CLO), our company’s product manager (TL), and an industry expert (IE) who has significant experience in bringing technology products to market. Luke Voelk (CLO) is Chief Technical Officer and cofounder of ObjectiveEd. Luke was the Entrepreneurial Lead in an NSF iCorps program for our BuddyBooks product, that uses AI to help students with dyslexia improve their reading skills. He is well-versed in use of a Business Model Canvas and has decision-making authority within the company to implement changes in direction regarding the overall commercialization strategy for the project. He implemented a pivot in the NSF project. At ObjectiveEd, Luke architected and created the technology infrastructure for the NSF-SBIR funded project, BuddyBooks. Prior to BuddyBooks at ObjectiveEd, he led the development team to bring to market over 20 skill-building apps for students with vision impairments (VI). The development staff, and the Product Manager, report to Luke. Prior to eSped, Luke was Director of Engineering at eSped, an EdTech company in the Special Ed market. Luke has a B.S. in Computer Science and Physics from Wesleyan University. August Voelk (TL) is the Product Manager for the AIF projects and has been with ObjectiveEd for 3 years. August was the Technical Lead for the NIDILRR IMPACT Program, a mini-bootcamp that helped our company understand the pain points and stakeholders AIF stories created for students with vision impairments. August coordinates the development and support teams to ensure the delivery of valuable and innovative new products, trains teachers and specialists in the use of our products, conduct seminars at key conferences and conducts in depth market research to develop new product opportunities. He graduated Franklin and Marshall College with a BA in Business and Economics. Luke and August have worked together at ObjectiveEd for 3 years. In addition to bringing the 20 skill- building VI games to market, they launched the two NIDILRR AIF story games to Special Ed departments in public schools. They launched BuddyBooks into both the public-school Special Ed market and the homeschool market (as a consumer product). While Luke (CLO) and August (TL) are both visionaries on product direction, Luke’s strengths include knowing how to translate customer dreams into deliverable products. August’s strengths are ensuring the products achieve the specific requirements and delight the customer. One example of a conflict between Luke and August is our product launch into the homeschool market for BuddyBooks. Luke’s analysis from NSF iCorps process led us to the homeschool market, while August perceived it as too distracting from the public-school market. Instead of Luke simply forcing the company to pursue the homeschool market, he presented the business case and convinced the other two founders, the board, and the other programmers that this was the proper path. Mark Ventre will be our team’s Industry Expert. Mark was the Chief Operating Officer for eSped, a company that provided compliance tracking and state/federal reporting for Special Education Departments. eSped provided services to over 1,000 school districts and managed reporting for 500,000 3 students and was the largest vendor in several states. eSped was strategically acquired by Frontline Education in 2016. Mark managed the company growth from startup to acquisition. Mark participated in the seed funding round for ObjectiveEd. Mark has reviewed the iCorps documents in the FOA and has availability consistent with the program timeframe. Deep commitment to the time-intensive requirements All team members are aware of 25 hours/week time commitment, and as a company, we are aware of the impact of the time commitment from our experience with NSF iCorps and NIDILRR bootcamp. In the two prior courses (NSF, NIDILRR), our understanding of the market evolved from the beginning of the course to its completion. We realized how we missed identifying all stakeholders, which exposed additional distribution channels, partnerships and revenue opportunities. We discovered the importance of certain factors – like acquiring proof of efficacy from the Dept. of Education, that opened additional grant funding for school districts to purchase our product. We were slightly skeptical of the business model canvas, when we started the NSF iCorp; we felt our prior Special Ed market experience was sufficient. We became advocates for this approach after seeing how effective it was for our company. We know the iCorps process will result in a deeper understanding of our market, which is needed for a successful Phase II proposal, and of course, a viable business. We are confident that if the Business Model Canvas identifies that we need to pivot, we’ll pivot. This administrative supplement will allow us to do sufficient customer investigation so that our research and development efforts are focused where the need is greatest. That ensures more college-bound students will be helped, and the company will achieve profitability sooner. During the NSF iCorps process for BuddyBooks, we acquired far more than the 100 required customer interactions. Not only did we have many Zoom conversations in the first week, but over the next two months, we attended 4 conferences and conventions to talk, face-to-face, to dozens of different types of stakeholders (competitors, parents, students, conference organizers, distribution partners, book publishers, teachers, tutors, principals, etc.). We understand the value of in-person customer discovery. 2. Potential Commercial Impact Market Opportunity College is one of life’s most important gateways to independence, success, and economic security, and college-bound students with ASD or ADHD are matriculating to college in record numbers. Despite being intellectually capable, many of these students do not make it to graduation. Only 44% of college students receive their degree – significantly less than the 60% graduation rate for all disability groups and the 67% rate for the general population. However, research consistently shows that these students need better transition planning throughout high school and continued accommodations in college, as they need to master self-regulation and executive function skills. Traditionally, counselors or teachers provide these skills. However, almost half of the public vocational rehabilitation agencies do not have sufficient staff to serve all clients properly. In some regions of the nation, there are no counselors and most Special Ed teachers are not trained to provide these skills. It is left to the parents, or other non-experts, who may not have the expertise, to prepare their student for college. Hence, there are two major problems that these college-bound students with ASD or ADHD face: § They need to master executive function skills. 4 § There are insufficient qualified counselors to provide this needed training. The Solution: College Readiness Stories (CRS) CRS is a transformative computer-mediated learning system for these students to independently improve college readiness skills. Research Scientists who study college readiness, and practicing transition counselors who provide college readiness training, have decades of experience in helping students build these skills. We capture their decades of experience and transform it into a virtual adventure story and a guide for non-experts, such as parents or Special Ed teachers. Instead of the student encountering difficult situations once they begin college, where multiple wrong decisions could result in the student getting bad grades, or dropping out of college, the student will encounter similar situations first in a safe, non-judgmental virtual story. Their “poor” decisions will result in bad outcomes, so the student can learn from their mistakes. Students will use the system independently, and won’t be as dependent on finding the excellent, but rare, counselor that will guide their transition. The system will include a Training Guide to empower the non-expert, such as a Special Ed teacher or parent, to assist the student and explain how the student can better manage difficult situations. CRS is implemented as an Accessible Interactive Fiction story game. We created our first two AIF stories as NIDILRR SBIR Phase I projects, where we realized how impactful this concept is. From testing with two different student populations, vision impairment and autism spectrum disorder, we found students enjoy learning using AIF stories, and teachers found significantly more student engagement. Market Size Based on 15% of college students having ADHD or ASD, with about 5 million students starting college each year, there are approximately 750,000 potential users (high school or starting college) who can benefit from a solution. Our conversations with these potential buyers indicate a $75 price per student per year is acceptable, yielding a total addressable market of $56 million per year. The Users The primary users for the system are the college-bound students and the non-experts who provide help to them. The Customers & Value Proposition The benefit of CRS is that more students will build executive functioning skills than the current methods (due to the counselor shortage) and that will result in more students graduating college. The customers that will benefit from this value proposition are: § Special Ed departments, that want students to enroll in college and achieve their goal of graduating from college. CRS will give students the confidence that they will succeed in college. § Universities and colleges that provide accommodations and support services to ADHD and ASD students. If students were well-prepared, through AIF stories, for the college workload, there would be fewer students dropping out or failing out. Colleges suffer financially when students leave without graduating. § Community colleges that offer students 2-year degrees, as a stepping-stone to a university B.A. or B.S. They want to prepare their students properly. Their reputation is based on the percentage of students graduating. § Parents who want their children to obtain a college education. 5 § College bound students, with plans to use their degree to improve their life, and not let their ASD or ADHD limit their opportunities. § Vocational Rehab agencies, who help transition-age students (16-21 years old) prepare for post- high school life. They are evaluated by their funders for the number of “successful” clients. § Department of Education agencies in each of the 50 states, whose mission is to improve education outcomes for both secondary and post-secondary students. Competition In most cases, executive functioning and time/task management is not emphasized in high school for students and is not addressed as part of a Special Ed curriculum. Some colleges offer freshman orientation classes where executive function skills are discusses, and some colleges offer personalized counseling assistance as part of their accommodations for students with special needs. These services provide brochures and videos to emphasize the importance of these skills and may include role-playing. CRS’s competitive advantage is that students will experience situations in a virtual adventure, so they learn from their mistakes. We intend to conduct efficacy studies that should show an improvement in executive functioning skills, such as the Behavior Rating Inventory of Executive Function (BRIEF) test. As a company, our key differentiators are (1) we are already a trusted supplier of digital curriculum for students with a range of disabilities to the Special Ed department of school districts, and (2) we have expertise in converting peer-reviewed research findings into educational products for students. We use these research findings to build software, often scaffolding on state-of- the-art (SOTA) commercially available technology as part of the solution, which reduces the time and the costs to get a product to market. Management Team Our company has been selling digital curriculum for students with disabilities to community agencies and school districts since 2021, and we have over 150 customers, including 4 of the largest 10 school districts including the Los Angeles USD. Our company has won numerous awards for EdTech innovation, such as the 2022 Global EdTechX Startup Winner, and the EdTech 2023 Breakthrough Award. Our management team has a combined 50 years of experience in the Special Education technology market. Intellectual Property Our company protects its Intellectual Property using two strategies and will use them with this CRS. Patent-based: We have filed for several provisional patents for our innovations, and will do the same for CRS. Trade-secrets: While the OED user interfaces and functionality could be duplicated in areas that are not copyright and patent protected, there are significant trade secrets that we vigorously protect. We have accumulated significant “know-how” during research and development of our AIF products – not just how to do things, but what not to do and what does not work optimally. For example, not all students in rural and low-income communities have access to the Internet at home. We’ve built technology to accommodate for this limitation. Partnerships & Collaborations We are partners with some of the largest research centers and advocacy groups for ASD (such as the National Autism Center/May Institute), the National Disability Institute and will do the same for ADHD. We collaborate with the Council for Exceptional Children, and many state-level agencies for Special Ed Directors, such as the Texas Council of Administrators of Special Education. We have developed relationships with several state-based vocational rehabilitation agencies for services for people with 6 disabilities, such as the Massachusetts Rehabilitation Commission and the Michigan Dept of Blind Services (who is helping to connect us with the Michigan Rehabilitation Services agency). Fundraising potential Our company has raised about $1.8M seed capital through angel investors, who are familiar with the prior successes of the founding management team. We will investigate a Series A after the CRS product has completed Phase II and we want to scale marketing and sales efforts. We do not foresee additional capital requirements until then; revenue from existing products sold to school districts is sufficient to maintain company viability. 3. Project Plan Our SBIR Phase 1 project will create one AIF story for a college-bound student to demonstrate feasibility and usability. We expect the story to be ready in the February timeframe and to begin testing it as a pilot study in March/April. The Principal Investigator (PI) will perform the following assessments after the student has used the AIF story: Tool Who? Description TOOL1 PI to student Survey for students to rate items that focus on their motivation to use the AIF story, its ease of use and accessibility, and if they would recommend it to others, what they liked and didn’t like. SUS1 PI to student The System Usability Scale, where the student rates the usability of the AIF story. TOOL2 PI to parent Survey for parents to identify the usefulness of the Training Guide, suggest improvements, and if they would recommend the use of the AIF story to other parents of college-bound students. SUS2 PI to parent SUS where the parent rates the usability of the Training Guide. In Phase II, we will create at least 8 multi-chapter stories that a student would use over one to two semesters, to build and practice skills. Project/Performance Site Once these stories are complete, we will test it with sufficient students (350) to obtain Dept of Education’s What Works Clearinghouse Tier 1 proof-of-efficacy. We will conduct this with several school districts and agencies who are already customers of our other products for students with disabilities, such as Pittsburgh Public Schools. Senior/Key Personnel PI: Martin Schultz CLO: Luke Voelk TL: August Voelk IE: Mark Ventre Protection for Human Subjects We have received IRB approval for this Phase I SBIR project. Inclusion of Women, Minorities, and Individuals Across the Lifespan This is non-clinical research but will include a balanced mix of women and minorities in student testing. Vertebrate Animals and Biohazards Our research does not include either of these categories.